CORE D ZEBRAFISH FACILITY

Program Director/Principal Investigator (Last, First, Middle): E l s e n , J u d i t h S . , P D CORE D. ZEBRAFISH FACILITY (J. EISEN, C. KIMMEL, M. WESTERFIELD, CO-DIRECTORS) INTRODUCTION: Reviewers made a number of useful recommendations for ways to improve our Zebrafish Facility, and they provided an overall high rating of this Core. As recommended by the reviewers, we have significanfiy decreased